Characterisation of drug resistance in field-collected schistosomes

Large-scale treatment programs with praziquantel (PZQ) monotherapy are the mainstay of efforts to control
and eliminate schistosomiasis. The potential for drug resistance in schistosomes is a critical area of
research as we scale up treatment coverage. In the laboratory, PZQ resistance (PZQ-R) is easily selected,
results in a >368-fold difference in drug response, and genetic analyses unambiguously identify a region of
chr. 3 containing a transient receptor potential (TRP) channel. In Western Kenya, approximately 30% of
schistosome-infected patients are egg-positive following treatment with PZQ, and in a recent study
(SCORE) we observed several “hotspot” villages that failed to lower infection intensities and prevalence,
despite multiple annual mass treatments with PZQ. One hypothesis is that PZQ-R contributes to the
observed failure of mass PZQ treatment to lower infection. In aim 1 we will ask whether the persistence
of infection in “hotspot” villages can be explained by resistance. We have established a novel
platform for testing for the extent of PZQ-R in individual adult schistosomes from a field setting. To do this
we have established a large snail breeding colony, and hamster breeding facility. We can therefore
generate large populations of field-derived adult worms, by (i) harvesting S. mansoni eggs from infected
patients, (ii) infecting snails with miracidia, (iii) infecting hamsters with released cercariae, and (iv) perfusing
adult worms from hamsters. We will screen the drug response of individual S. mansoni worms maintained
on 96-well plates and exposed to PZQ using a simple L-Lactate assay. Using this approach, we will directly
compare resistance status of parasites from hotspot and non-hotspot villages. We will also compare pools
of PZQ-R and PZQ-S parasites isolated from the field to determine the genome regions that underlie the
differences observed, and to test the hypothesis that genetic variation in the TRP channel on chr. 3
underlies PZQ resistance in the field. In aim 2 we will exploit our unique platform to examine genetic
variation for resistance to new schistosome drugs. A suite of compounds showing strong activity
against schistosomes is now available. Recent field studies have shown high levels of naturally occurring
resistance to oxamniquine in East Africa where this drug has been minimally used, and comparable work
with the free-living nematode C. elegans shows naturally occurring resistance to a range of anthelmintic
compounds. We will critically test the hypothesis that “standing variation” for resistance is common against
schistosome drugs under development. We will then compare individual worms at the extremes of the drug
response spectrum to identify the genetic basis of resistance. The knowledge gained will be critical to on-
going schistosomiasis elimination efforts through mass PZQ treatment and will provide valuable information
for the development of new anti-schistosome drugs. The project will also stimulate development of research
capacity in genome sequencing, computational biology and anthelminthic pharmacology in Kenya.

Public health relevance
NARRATIVE PZQ monotherapy is used to treat schistosome infection, and so evolution of PZQ resistance is a major concern, and new drugs are urgently needed. We have developed a unique platform that I will use to examine drug response in individual field derived schistosomes. This will allow us to (i) examine the prevalence of PZQ resistance in the field and their contribution to treatment failure, (ii) to determine the genome regions underlying resistance, (iii) to determine the genes underlying resistance to other schistosome drugs under development.